Defining a biophysical basis for cell types, cell states and cellular heterogeneity at single-cell resolution

Project Summary.
Cells are dynamic and highly responsive systems that integrate internal molecular signals with external biological
cues to establish unique time-dependent cellular identities. These cellular identities, which we can think of as
cell types, cell states, or cell fates change in the context of health and disease. Recent advances in single-cell
technologies have provided the unprecedented capacity to profile cellular states, reconstruct cellular lineages,
and identify putative drivers of diseases across thousands of individual cells. Our long terms goal is to
comprehensively and systematically understand how the flow of biological information from underlying molecular
programs to behaviors and responses define cellular identities. Building on current work within my lab, we will
develop new integrated technologies to investigate how distinct molecular programs drive cell behaviors and
cellular responses to perturbations at single-cell resolution. As model systems, we will investigate how distinct
epigenomic programs drive senescence phenotypes, how transcriptional program modulate T-cell behaviors and
responses with application for engineered cells, and lastly how mapping phenotypic changes of T-cells during
differentiation could help us better understand cell types and cell commitments. Collectively, the proposed
studies, which are backed by strong preliminary data, will yield substantial new information on cell-based
mechanisms and provide new ways to deeply profile single cells.

Public health relevance
Project Narrative. Cell are highly adaptable and dynamic systems that change in response to biological signals and perturbations. Recent advances in single-cell technologies have provided an unprecedented capacity to profile cellular identities that are tied to underlying molecular states. We propose to build on these advances to develop complementary image-based and computational approaches to decipher how underlying molecular states of cells drive unique single-cell phenotypes and responses in health and disease.